Racial Difference in Prostate Cancer

SUMMARY Men of West African ancestry (AA) in the United States have the highest risk of prostate cancer (PC)
globally, and AA men frequently present with more aggressive disease. In the previous funding period, our goal
was to identify master transcription factors (MTFs) that function more often in AA in comparison to EA PC. The
competitive renewal project is based on our discovery of a novel interaction between Kaiso, an AA-associated
TF, and ONECUT2 (OC2), a race-independent TF. Both of these MTFs are established malignancy drivers.
Importantly, we have demonstrated that OC2 is directly targetable with a novel family of small molecule inhibitors
(OC2i) that suppress established CRPC metastases in mice. We assembled a large dataset supporting a
proposed genome-wide functional interaction between Kaiso and OC2. In this project we will investigate the role
of this interaction in PC progression, and its potential therapeutic relevance, using in vitro models, quantitative
analysis of human PC tissues, and pre-clinical studies of human patient-derived xenografts (PDXs) and PDX-
derived organoids. Our results suggest that Kaiso and OC2 co-regulate a large gene expression network that
promotes lineage plasticity and metastatic progression in PC cells, and that this network can potentially be
suppressed by pharmacologic inhibition with OC2i. We will test two hypotheses in this project: 1) Kaiso
cooperates with OC2 to promote lineage plasticity and drug resistance; and 2) Kaiso-active prostate tumors can
be suppressed by pharmacologic inhibition of OC2. The Specific Aims are: Aim 1: Establish the role of the
Kaiso-OC2 interaction in PC progression to lethal disease. In this aim we will elucidate the interdependence
of the OC2 and Kaiso transcriptional programs, identify unique and inter-dependent OC2 and Kaiso chromatin
partners and determine their functional roles, and determine the susceptibility of Kaiso activity to OC2 inhibition.
Aim 2: Characterize the Kaiso-OC2 interaction and its effects on cell plasticity in AA and EA PC. Both
OC2 and Kaiso traffic between the cytoplasm and nucleus. In this aim we will use multiplexed tissue staining,
spatial transcriptomics and quantitative image analysis to assess whether OC2 and Kaiso expression and/or
subcellular localization are biomarkers of PC lineage plasticity. Aim 3: Determine whether Kaiso-active
tumors can be suppressed by OC2 inhibition. Because Kaiso activity correlates strongly with OC2 activity in
diverse datasets, we will use human PDX models to determine whether Kaiso-active tumors can be suppressed
by pharmacologic OC2 inhibition. Impact: These studies present a new avenue for deeper mechanistic
understanding of PC lineage plasticity and scenarios of drug resistance in AA and EA men.

Public health relevance
Narrative This project is based on a large dataset we have assembled that supports a role for an extensive gene expression network co-regulated by the master transcription factors (MTFs) Kaiso and ONECUT2 (OC2) in prostate cancer progression to lethal disease. We will test two hypotheses: 1) that Kaiso, which has been associated with prostate cancer in African-American men, cooperates with OC2 to promote lineage plasticity and therapy resistance; and 2) that Kaiso-active prostate tumors can be suppressed by pharmacologic inhibition of OC2.